UW ALACRITY Center for Psychosocial Interventions Research

ABSTRACT. The purpose of the UW ALACRITY Center is to address critical problems in the implementation of
evidence-based psychosocial clinical interventions (CI) (e.g., psychotherapies) in nonspecialty service settings
that are accessible to underserved communities (i.e., primary care clinics and schools). Use of CI is inhibited by
longstanding problems with the usability, contextual fit, and engagement of both those CI and the implementation
strategies (IS) (e.g., consultation models) the support them. This situation also results in high rates of “reactive
adaptations” of CI/IS by their intended users in many settings where they are deployed. Building on our learnings
and successes over the past 4 years, our interdisciplinary research team will draw from the fields of human-
centered design (Drs. Munson, Fogarty), implementation science (Drs. Lyon, Bennett, Locke, Fortney, Bruns,
van Draanen), psychosocial CIs (Drs. Areán, Raue, McCauley, Bearss, Walker), and research methods/data
analysis (Drs. Pullmann, Dopp). The Center represents a unique partnership between the School of Medicine’s
Departments of Psychiatry and Family Medicine, the Department of Human-Centered Design and Engineering,
the Department of Computer Science, the School of Social Work, the School of Public Health, and the College
of Education. The Center also bridges UW’s many resources: The Institute for Translational Health Sciences
(the UW CTSA), the AIMS Center (UW implementation center for collaborative care), the SMART Center (UW
implementation center for education sector services), the WWAMI-region Practice Research Network (WPRN,
primary care practices in Washington, Wyoming, Alaska, Montana and Idaho), and the MHTTC Northwest School
Mental Health Network (public school districts across Washington, Oregon, Alaska, Idaho). The Administrative
Core (AC) will serve as the communication hub between Center cores and advisory boards; oversee the selection
of pilot studies; and coordinate mentoring, evaluation, and dissemination. The Methods Core (MC) will provide
research infrastructure to projects and support use of our Discover, Design/Build, Test (DDBT) framework to
address CI/IS usability, engagement, and appropriateness in partnership with local stakeholders. The MC will
also compile project data to update and refine our Typology of CI/IS Modification Targets and Library of Redesign
Solutions for dissemination and assess costs of DDBT-driven redesign. Research projects will collect common
outcome data to determine the impact of modifying CI/IS targets. The Signature R01 will test a DDBT-designed
decision support tool for Problem Solving Treatment in a large network of primary care clinics. R34 #1 will create
a novel IS to support delivery of evidence-based classroom supports for students on the autism spectrum. R34
#2 will modify a well-researched CI for youth trauma for use in education settings. R34 #3 will adapt an existing
effective IS to enhance delivery of school mental health assessment and triage. All four projects, and future pilot
projects, will test effects of redesign on usability, appropriateness, engagement, implementation outcomes, and
patient outcomes.

Public health relevance
PUBLIC NARRATIVE. Psychosocial clinical interventions are the preferred mode of treatment for most people seeking care for mental health problems – particularly among people of color and those living in poverty in both rural and urban communities – but very few people have access to them because of the problems with usability, contextual fit, and engagement experienced when those interventions and the implementation strategies designed to support their use are deployed in accessible settings like primary care medicine and schools. The UW ALACRITY Center will address these issues by advancing its novel framework for redesigning clinical interventions and implementation strategies, drawing from the fields of human-centered design and implementation science. Across projects, the UW ALACRITY team will work with local practitioners and other stakeholders to develop and test four new solutions for addressing problems in the usability, contextual fit, and engagement of clinical interventions and implementation strategies in primary care and schools and will support additional pilot studies over the 5-year timeline.